Expanding single-cell and spatial technologies to link clonal genotypeswith phenotypes during cancer evolution

ABSTRACT
Clonal expansions are observed in a wide range of normal human tissues, as well as in cancer evolution.
These outgrowths lead to clonal heterogeneity which can drive the development of treatment-resistant disease.
Clones contain somatic mutations in known cancer driver genes and show evidence of positive selection.
However, how these driver mutations potentiate changes to the cellular states of cells to allow clones to
outcompete neighboring wild-type counterparts remains poorly characterized. So far, the identification of clonal
outgrowths in normal or malignant human tissues has been mostly restricted to genotyping analysis only, as
these clones often constitute a minority of cells in a sample and do not have distinguishable cell-surface
markers. To address the challenge of charting clonal outgrowth during somatic and cancer evolution, we
developed a range of advanced single-cell technologies that can capture multiple layers of information from a
single cell. These technologies can gather information on genotypes, transcriptomes, methylomes, and protein
expression. To overcome the challenge of genotyping using single-cell RNA sequencing, we developed the
Genotyping of Transcriptomes (GoT) technique. With GoT, we can compare mutant and wild-type cells within
the same individual to characterize the transcriptional consequences of somatic mutations. To further study the
molecular mechanisms of how somatic mutations give clonal growth advantage, we have extended our multi-
omics single-cell toolkit to include other modalities. As epigenetic mutations are highly frequent in cancer, we
developed and applied targeted single-cell genotyping and single-cell ATAC-seq (GoT-ChA), which provides
genotyping information in the context of chromatin accessibility. We aim to further expand our platform by
developing single-cell methods to capture additional chromatin features, including post-translational
modifications of histones (GoT-NTT), transcription factor binding (D&D-seq/GoT-D&D), and high-throughput
automated joint measurement of RNA expression and whole genome sequencing (SMART-PTA). Additionally,
to define clonal driver genotypes in their spatial context, we will adapt spatial transcriptomics by adding the
critical feature of genotyping (GoT-Stradivari), allowing us to characterize how clone growth is affected by its
interaction with the microenvironment. Our ultimate goal is to identify the underpinnings of fitness advantage in
clonal outgrowth by generating multi-omic comparisons at the single-cell level between wild-type and mutant
cells. The proposed comprehensive GoT toolkit will enable us to link single-cell genotypes with transcriptional,
protein, epigenetic, and spatial phenotypes at high throughput. We believe that these advances will transform
the study of clonal mosaicism as a harbinger of cancer and resistance to cancer therapies.

Public health relevance
PROJECT NARRATIVE Cancer mutations drive the outgrowth of small populations of cells in normal tissue, years before clinical diagnosis of cancer, or the outgrowth of cells resistant to therapy. However, how such mutations change cellular behavior to provide them with a competitive growth advantage over adjacent cells remains poorly understood. To address this gap in knowledge, we propose to apply and develop novel single-cell sequencing technologies to study the mechanisms underlying growth advantage in cancer.